Cellular commitment to mortality: analyses of mouse early embryo

In our previous work, we carried out microarray-based global expression profiling of all preimplantation stages in mouse. They revealed and characterized distinctive patterns of maternal RNA degradation and two major transient waves of de novo transcription. The first wave corresponds to zygotic genome activation (ZGA); the second wave, named mid-preimplantation gene activation (MGA), precedes the dynamic morphological and functional changes from the morula to blastocyst stage. We also developed a technique to do large-scale Whole Mount In Situ Hybridization (WISH), which allows us to reveal the spatial expression patterns of 91 genes in mouse preimplantation embryos. Through these analyses, we identified a number of genes that show unique expression patterns. As an example of ZGA genes, we found Zscan4, which is expressed exclusively in 2-cell mouse embryos and ES cells and plays a critical role in the progression of preimplantation development. As an example of MGA genes, we found Trim43. We showed that the downregulation of Zscan4 expression in 2-cell embryos by shRNAs delays the normal transition from 2-cell embryos to 4-cell embryos for about 24 hours, resulting in abnormal blastocysts that failed to implant in the uterus. This indicates a critical role of Zscan4 in preimplantation development. We also found that Zscan4 is expressed only in late 2-cell embryos and in the subpopulation (1 - 5%) of ES cells maintained in the undifferentiated condition. We found that other 2-cell-specific genes are also highly expressed in Zscan4(+) cells. This indicates that the subpopulation of ES cells marked by Zscan4 expression shows some resemblance to 2-cell embryos, whereas the majority of ES cells show similarities to the Inner Cell Mass (ICM) cells in blastocysts. Zscan4 is thus associated with a unique transient state in undifferentiated ES cells, in which other 2-cell embryo-specific genes are activated. By carrying out cell lineage tracing experiments, we have found that, although Zscan4 is expressed only in 5% of ES cells in culture at a given time, essentially all ES cells experience a Zscan4-positive state by 9 passages. By knocking down Zscan4 activation with an shRNA, we have found that Zscan4 is essential for the long-term maintenance of genomic integrity and for mediating a regulated telomere recombination in normal undifferentiated ES cells, therefore making it indispensable for the proper long-term self-renewal in ES cells. We have also found that Zscan4 is involved in the induction and recruitment of the meiosis-specific homologous recombination machinery to telomeres. Recently we have shown that Zscan4 can be used as one of the reprogramming factors and enhances the quantity and quality of induced pluripotent stem (iPS) cells.